Mechanisms of Translational Dysregulation in Huntington disease

This investigation aimed to identify the mechanisms and molecular functions of ribosome stalling in Huntington
disease (HD). HD is caused by the polyglutamine (CAG) expansion of huntingtin (mHTT), which promotes
neurodegeneration in the brain, causing motor, cognitive, and psychiatric symptoms. Multiple abnormal functions
have been proposed for mHTT, but its pathogenic mechanisms remain unclear. Using super-resolution ribosome
profiling (aka Ribo-Seq) and biochemical tools, we demonstrate that mHTT promotes ribosome stalling and
inhibits protein synthesis, which is the topic of the current investigation. The central hypothesis is that mHTT
interacts with RNA and ribosomal binding proteins (RBPs) to inhibit ribosomal movement and increase
HD pathogenesis. Our published and preliminary data indicate that mHTT copurifies with 40S ribosomal
subunits, directly binds to elongating ribosomes, and suppresses protein synthesis both in vitro and in vivo.
Interestingly, Ribo-Seq revealed that mHTT mRNA exon1 also had substantial ribosome occupancy before CAG
expanded repeats, which we validated using biochemical reporter experiments. We found that the RBP fragile
x-mental retardation protein (Fmrp), a negative regulator of synaptic mRNA translation, is upregulated in HD and
that Fmrp deletion inhibits age-dependent motor deficits in a humanized HD model. On the basis of these solid
data, the proposed research has three interrelated objectives: 1) to identify the ribosome-bound protein/RNA
component that interacts with mHTT; 2) to determine the mechanisms of ribosome stalling on mHTT mRNA; and
2) to delineate the role of Fmrp in modulating protein synthesis at the synaptic level in HD. Consequently, the
outcomes will likely reveal novel hypothesis-generating ribosome stalling mechanisms in HD, identify critical cis
and trans components implicated in mHTT RNA stalling, and determine how the mHTT-Fmrp nexus regulates
aberrant synaptic translation in HD. These findings will help develop translation mechanism-based treatment
and diagnostic modalities for poorly understood neurological illnesses.

Public health relevance
The proposed work is relevant to public health because the discovery of molecular mechanisms of ribosome stalling regulation in Huntington disease is ultimately expected to increase understanding of the neuronal vulnerability in diseases such as Parkinson disease, as well as provide framework for developing novel therapeutic strategies, based on mechanisms-based approaches. Thus, the proposed research is relevant to the part of NIH's mission that pertains to acquiring basic insights that will aid to lessen the pain of human of disability.